Project 2: Environmental forcing of harmful algal blooms and toxicity exposure

Our goal is to understand and predict how environmental variability influences harmful algal
bloom (HAB) dynamics and exposure of human populations to HAB toxins, with implications for
human health. We hypothesize that environmental changes will influence the composition,
distribution, and severity of HABs in ways that are predictable based on response to previous
environmental forcing. Our studies will focus on the dinoflagellate Alexandrium catenella and
diatoms of the genus Pseudo-nitzschia, organisms that produce saxitoxin and domoic acid,
respectively. Focusing on the Gulf of Maine (GOM), we will construct hindcast simulations into
which a revised model of A. catenella model and a to-be-developed model of Pseudo-nitzschia
spp. will be incorporated. The A. catenella model revisions will incorporate the latest advances
in how cyst germination and loss processes affect bloom timing and development. Hindcasts will
be evaluated against observations, documenting fluctuations in abundance of the target species
as well as toxicity (toxin accumulation) in coastal shellfish resources. A submodel will be
developed to estimate human exposure to these toxins. Discrepancies between the hindcasts
and observations will guide iterative model improvement. Once satisfactory agreement has
been achieved, the models will be run in forecast mode. We will also assess HAB dynamics in
two other model systems: a temperate embayment with Nauset Marsh (NM) and the coastal
Arctic. The proposed research will be integrated into the WHCOHH in several ways: (1) what is
learned about bloom dynamics in Project 1 will be used to improve HAB models; (2)
development of the exposure submodel will be undertaken in collaboration with Project 3; (3) all
three projects will participate in the analysis of environmentally-forced variations in HABs and
how they affect human exposure to toxins; and (4) results will be communicated through the
Community Engagement Core.